The STOP-HPV Scale-Up Study

Abstract
Human papillomavirus (HPV) causes 33,700 US cancer cases per year, 4,000 deaths and $4 billion in cancer-
related medical costs. Despite an effective vaccine, in 2020 less than 60% of US adolescents 13-17 years of
age completed their HPV vaccine series. Key barriers are suboptimal clinician communication to address
parental vaccine hesitancy, and ineffective office systems causing missed opportunities for vaccination.
Our research team tested two promising implementation strategies (ISs) in primary care practices to address
these barriers: online clinician communication training (“STOP-HPV-Online”) which trains clinicians on
communication techniques and addresses parent hesitancy, and a multi-component IS (“STOP-HPV-LC”) that
involves both clinician communication training plus office-based changes in workflow learned on monthly learning
collaborative group phone calls. Both ISs were deployed by our research team. Widespread scalability requires
the ISs to be deployed by health systems since most primary care practices are now part of health systems.
For Aim 1 we will adapt the two ISs for deployment by 8 health systems, and also describe baseline strategies
used by these systems. We will partner with the American Medical Group Association® (AMGA),the main national
organization of health systems. More than 8 health systems have already expressed interest in the study. We
will use a mixed-methods approach and the RE-Aim/PRISM framework to evaluate the effectiveness and
implementation processes of the health-system deployed implementation strategies. We will assess how health
systems deploy core IS functions and how they and practices adapt specific activities (forms) within each IS.
Aims 2-3 will use a 3-arm clustered RCT, randomizing 72 practices within the 8 health systems to STOP-HPV-
Online, STOP-HPV-LC, or usual care control. Aim 2 will compare the effectiveness and cost-effectiveness of
the two ISs to control and to each other over a 12-month IS period and another 12-month maintenance period.
The primary outcome for Aim 2 is HPV vaccine initiation; secondary outcomes are vaccine series completion
and cost-effectiveness of the IS.
Aim 3 will assess provider, practice, and health system factors relevant to implementation of the two ISs. The
primary outcome is adoption (uptake of core IS functions such as clinicians completing the online modules);
secondary outcomes include reach (e.g., % clinicians participating), practice/provider factors (e.g.,
organizational readiness) associated with improvement in rates, and maintenance of core IS functions by
practices over 12 additional months. We will develop and disseminate online implementation guides for health
systems and practices to use, and AMGA will help spread the ISs to their other health systems.
By the end of the study, we will have two scalable ISs for AMGA and any health system to improve HPV
vaccination rates and reduce HPV-related cancers.

Public health relevance
Narrative Human papillomavirus (HPV) causes enormous morbidity, yet despite a safe and effective HPV vaccine, adolescent HPV vaccination rates are low due to parental vaccine hesitancy, suboptimal clinician communication, and ineffective procedures within primary care practices. We have developed two potentially scalable implementation strategies to raise vaccination rates: one trains clinicians on optimal HPV vaccine communication while the other adds practice-based changes in HPV vaccine workflow processes; both have been found to be effective on a limited scale. We are partnering with 8 health systems and 72 practices to compare the effectiveness and cost-effectiveness of the two implementation strategies and to assess provider, practice, and health system factors relevant to their implementation; the ultimate goal is to develop two nationally scalable implementation strategies to raise HPV vaccination rates.